Mechanisms of Eukaryotic Translation with a Focus on Induced Nonsense Suppression

SUMMARY
We propose to determine i) the specific effects on eukaryotic translation of posttranscriptional modifications (PTMs) of
mRNA and tRNA and ii) how readthrough of premature termination codons (PTCs) is modulated by downstream sequence
context and stimulated by translation readthrough inducing drugs (TRIDs). In so doing we will contribute to the
development of new therapeutic approaches for treatment of diseases which are linked to PTMs and PTCs. Our approach
is to apply a reconstituted in vitro system, denoted PURE‐LITE, to elucidate mechanisms of elongation and termination
using a combination of ensemble and single molecule approaches. Such studies can aid in interpreting the results of
related cellular and clinical studies and suggest new directions to pursue. Our Specific Aims are: 1. Determine the effects
of mRNA and tRNA posttranscriptional modifications on elongation and termination. m6A, pseudoU (,inosine (I) and
m5C are among the most common PTMs of eukaryotic mRNA. There currently are no direct measurements of how these
PTMs affect cognate elongation, misreading, readthrough and termination. We will determine which modifications have
the most pronounced effects on these processes and identify which steps during elongation and termination are
responsible for these effects, which are the most likely to be involved in altering translational functions in cells. We will
prepare mRNAs containing modifications in sense or nonsense codons, pair these modified codons with cognate and near‐
cognate tRNAs for the three elongation processes, and compare the rates and stoichiometries of elongation with those
obtained with the corresponding unmodified mRNAs and tRNAs. tRNAs will be selected to examine how different
modifications of nucleotides 34 and 37 of the anticodon loop affect assay results. Similar studies for termination will
compare modified and unmodified mRNAs. 2. Determine the effects on readthrough of UGA codons of downstream
sequence context and TRID termination inhibitors. There is strong evidence that UGA PTCs are the most susceptible to
readthrough and that sequences immediately downstream from a UGA PTC influence readthrough efficiency. Our results
have demonstrated that ataluren, the only TRID currently approved for treating patients with a PTC disease, acts
exclusively by competitively inhibiting release factor complex (RFC). Ataluren shows variable results in stimulating
readthrough, as measured in cell‐based assays and clinical trials. We hypothesize that this variability may be a
consequence of how PTC downstream sequence affects RFC activity. We will test this hypothesis by determining how
closely ataluren inhibition of RFC as a function of downstream sequence correlates with ataluren stimulation of
readthrough activity. Such tests will be repeated with ataluren added in combination with agents which stimulate
readthrough by a mechanism orthogonal to that of ataluren, potentially leading to synergistic results. The most effective
combinations will also be tested in cellular assays. In parallel experiments we will seek to identify TRID termination
inhibitors more potent than ataluren, via high throughput screening with a plate reader assay, virtual screening and
medicinal chemistry. These parallel efforts should improve the treatment of PTC‐based diseases and the selection of
patients most likely to benefit from such treatments.

Public health relevance
NARRATIVE Protein synthesis is a key process in cellular function. A common cause of many genetic diseases is type of harmful mutation which interrupts the formation of many cellular proteins, depriving cells of activities necessary for normal function. In this proposal we seek to broaden our understanding of the mechanisms of protein synthesis and use that understanding to develop therapeutic approaches to overcome these harmful mutations.